LONG TERM OUTCOMES--CHILDREN ADMITTED TO PEDIATRIC INTENSIVE CARE UNIT

Goals of study are to measure the different domains of Health-Related Quality of Life among children between the ages of 2 and 12 years who were hospitalized in the Pediatric Intensive Care Unit of Texas Children's Hospital between December 1995 and November 1997. (CAP Protocol) We are currently completing one year of follow-up. At one year, we have approximately 50 pts, (19.3%) who are lost to follow-up.